Motivational enhancement to augment contingency management for SARS-CoV-2 testing and vaccination utilization among syringe exchange clients

PROJECT SUMMARY
People who inject drugs (PWIDs) are highly vulnerable to contracting SARS-CoV-2 and to the effects of the
disease caused by SARS-CoV-2, coronavirus disease 2019 (COVID-19). PWIDs experience underlying
medical conditions and unstable housing that put them at increased risk for COVID-19 morbidity and mortality.
PWIDs also experience barriers such as a history of stigmatization and discrimination by health care systems
and exposure to misinformation that reduces access to health care services, such as SARS-CoV-2 testing and
vaccination. The proposed project builds on our Phase I Rapid Acceleration of Diagnostics project (#67; PI:
Stormshak) that successfully embedded SARS-CoV-2 testing into syringe exchange programs (SEPs) across
the state of Oregon, in collaboration with HIV Alliance (HIVA). The testing program’s success is linked to a
contingency management (CM) intervention that increased the rates of testing utilization from 4% to 24% (d =
1.36), even as nationwide testing utilization was decreasing. The first aim of the proposed project is to test the
sustained effectiveness of CM on testing outcomes, given the current context of increasing COVID-19 vaccine
accessibility. Testing remains critical to prevent the transmission of SARS-CoV-2 among PWIDs who continue
to be at high exposure risk, and for whom vaccine hesitancy is high. We will also leverage our partnership with
HIVA to establish a COVID-19 vaccine program at HIVA’s SEPs. The second aim is to conduct a randomized
control trial (RCT) to examine whether a brief motivational enhancement (ME) intervention (i.e., Connect2Test)
augments the effects of CM on SARS-CoV-2 testing and vaccination uptake. Our Phase I study demonstrates
that CM improves SARS-CoV-2 testing utilization. CM is also known to increase immunization rates against
other infectious diseases, such as Hepatitis B. Additionally, consistent with research showing that ME
enhances the effects of CM on health behavior outcomes, we anticipate that Connect2Test will augment CM’s
effects on testing and vaccination among PWIDs. Moreover, because ME elicits and strengthens motivation for
long-term behavior change, whereas CM prompts immediate and short-term behavior change, we anticipate
that CM + ME, versus CM alone, will have long-term effects on SARS-CoV-2 testing, evidenced by
participation in repeated testing over time. The third aim of the proposed project is to assess CM and
Connect2Test implementation, including a cost-effectiveness analysis of CM alone versus CM plus
Connect2Test, to improve long-term sustainability of testing, vaccination, and intervention approaches to
mitigate the spread of SARS-CoV-2.

Public health relevance
PROJECT NARRATIVE People who inject drugs (PWIDs) are highly vulnerable to SARS-CoV-2 infection and to the disease caused by SARS-CoV-2, coronavirus disease 2019 (COVID-19), however, rates of SARS-CoV-2 testing and vaccination uptake —vital to mitigating the spread of COVID-19 and achieving herd immunity — are lower among PWIDs compared to the general population. Building on our Phase I Rapid Acceleration of Diagnostics project, which found that contingency management (CM) increased testing utilization among PWIDs, the proposed project evaluates the comparative effectiveness of CM versus CM plus a brief motivational enhancement intervention on SARS-CoV-2 testing and vaccination uptake among PWIDs. This project has the potential to reduce COVID-19 health disparities among PWIDs and to decrease population level COVID-19 morbidity and mortality.